Mechanisms of Yersinia Enterocolitica Interaction with the Gut Microbiota

PROJECT SUMMARY/ABSTRACT
The gut microbiota antagonizes infection with enteric pathogens in a process termed
colonization resistance. Short chain fatty acids are considered a key component of
colonization resistance, however, despite decades of research, the mechanism(s) of how
short chain fatty acids exert colonization resistance and impede pathogen growth are
incompletely understood. One of the main challenges in defining the mechanisms of short
chain fatty acid toxicity has been that many gut bacteria, including enteric pathogens are
inherently resistant. Disentangling mechanisms of toxicity and resistance has proven to
be a major challenge. We discovered that Yersinia enterocolitica, a common cause of
foodborne illness, is exquisitely sensitive to propionate under specific in vitro conditions,
while fully resistant in other conditions. We posit that this this curious observation poses
a unique opportunity to discover mechanisms of short chain fatty acid toxicity, as well as
mechanisms of resistance. Based on our preliminary studies, we propose that propionate
is erroneously converted by acetate kinase (AckA) and phosphate acetyltransferase (Pta)
to propionyl-CoA, thus ensnaring the CoA pool and impeding acetyl-CoA metabolism. We
will test key aspects of our hypothesis in vitro and in mouse models of infection using a
strategic combination of bacterial and host genetics, metabolomics, and transcriptomics.
We will pursue the following specific aims: 1. Determine the mechanism of propionate-
mediated toxicity, and 2. Investigate the molecular mechanism(s) underlying Y.
enterocolitica resistance to propionate in vitro and in vivo. Successful completion of this
work is expected to reveal a novel molecular mechanism of short chain fatty acid-mediated
toxicity; since Pta and AckA are widespread in bacteria, this mechanism may be applicable
to gut bacteria in general. As such, these studies will advance our mechanistic
understanding of how colonization resistance is achieved by the gut microbiota, and how
enteric pathogens such as Y. enterocolitica can overcome colonization resistance.

Public health relevance
PROJECT NARRATIVE Yersinia enterocolitica infection is a common cause of bacterial diarrheal disease in the United States, with an estimated 97,656 infections per year (2018) and an estimated cost of Yersinia enterocolitica- food borne illness of $313,297,920 annually (USDA, 2018) due to premature death, lost productivity, and the cost of medical care. Furthermore, Yersinia enterocolitica is responsible for ∼60% of the reported cases of RBC (transfusion)-associated sepsis, of which ∼70% are fatal. A better understanding of the metabolism of bacterial pathogens is expected to aid in the development of new intervention strategies.